A Multiplex Analyzer for Sepsis Management

PROJECT SUMMARY/ABSTRACT
Sepsis, a life-threatening organ dysfunction accounts for over 50 million cases globally and is the leading cause
of death. Early intervention via antibiotic therapy, ventilator management, blood glucose maintenance, red blood
cell transfusions, and fluid resuscitative strategies reduce mortality from sepsis when supported by appropriate
diagnostics and ongoing monitoring. Notably, the latest Surviving Sepsis Campaign guidelines (Sepsis-3) has
established blood lactate levels as a key vital sign for septic shock and acknowledged that early management of
infection can reverse lactic acidosis and shock status. Every hour of delay in treatment from the time of diagnosis
to antibiotic therapy increases mortality of septic shock by 7.6%. Thus, there has been great interest in culture-
independent analysis at the point of care for early sepsis diagnosis, management, and prevention of antibiotic
overuse. Current clinical literature has highlighted lactate, glucose, hematocrit, and oxygen saturation as early
biomarkers of sepsis diagnosis and ongoing monitoring of therapy, be it fluid resuscitations to deal with
hypoperfusion; insulin infusion to deal with hyperglycemia; packed blood cell transfusions to deal with anemia;
or oxygenation therapies to deal with shock. However, compliance with the Sepsis-3 mandated timely lactate and
other analytical measurements is poor due to various pre-analytical and analytical challenges. Notably, capillary
blood glucose monitoring devices based on strips are labor intensive and erroneous, while blood gas analyzers
have long turnaround times and waste substantial blood volume in patients who may already be anemic. Timely
knowledge of the big 4 critical analytes (glucose, lactate, hematocrit and ScvO2) can allow prompt and
appropriate administration of antibiotic therapy and supporting interventions thereby significantly reducing
morbidity and mortality. This forms the basis of the patient-attached automated 4-plex measurement system
proposed by Cascade Metrix (CMX).
The CMX Automated Multiplex Analyzer (AutoPlexer) is a patient-attached system that enables timely, accurate,
and cost-efficient delivery of automated lactate, glucose, hematocrit and oxygen saturation measurements in
whole blood using proven electrochemistry and spectrophotometry without the need for any caregiver sample
handling of infectious blood or any blood loss to the patient. The AutoPlexer system performs measurements at
user-defined intervals or on-demand by pulling micro-volumes of blood across the sensors for measurement
followed by a safe return of the blood using saline in a completely closed-loop, heparin-free, sterilized and
biocompatible tubing-based blood pathway. Prior to each measurement, the system performs an automatic
calibration to ensure high accuracy. A pilot pre-clinical study in rat and swine models has been performed which
helped validate the preliminary design of the prototype for automated glucose measurements. The intent of this
Phase I application is to further develop the existing architecture to allow for “simultaneous” glu, lac, hct and
ScvO2 measurements using a single blood sample followed by preclinical validation of the resulting AutoPlexer
solution.

Public health relevance
PROJECT NARRATIVE Early diagnosis of Sepsis and ongoing monitoring of therapy is associated with significantly better clinical outcomes and lower health care costs. Achieving this demands efficient, safe, and accurate monitoring of multiple vital blood parameters notably, lactate, glucose, hematocrit and central venous oxygen saturation. The proposed development effort will be a key milestone in the introduction of an ex-vivo patient-attached automated multiplex analyzer for timely diagnosis and therapeutic monitoring of sepsis in critical care settings.